Animal Physiology Core

The Animal Physiology Core (APC) provides a comprehensive array of services overseen by Dr. Habegger with
three Associate Directors and incorporates a high level of expertise in the areas of integrative physiology, glucose
homeostasis, mitochondrial metabolism and redox biology, and animal models as a core resource for the study
of diabetes and cardiometabolic disease. The goal of the APC is to provide easy access to highly-specialized
equipment, technology, and expertise in the area of body composition, energetics, glucose homeostasis,
cardiovascular assessment, imaging, and transgenic animal models and technology to augment diabetes
research capacity, quality, and cost effectiveness.
The Specific Aims of the Core are:
1. To provide expertise in the use of animal models for diabetes research;
2. To provide state-of-the-art instrumentation and methodology for the determination of: Body
composition, Energy expenditure and balance, Substrate metabolism, Glucose homeostasis, Insulin
sensitivity and secretion, Mitochondria & Cellular Metabolism, Oxidative & Hormonal Stress, and the
generation of Genetically modified animal models.
3. To provide cost-efficient services to Core users; and
4. To promote interactions among investigators and to provide training in animal models and
phenotyping methods.
Since the APC was founded with the DRC in 2008, the track record of utilization and productivity has been
outstanding and is growing. The high quality, breadth, and cutting-edge nature of the Core’s technologies, and
responsiveness to the evolving needs of our investigators, have resulted in high rates of utilization by the DRC
research base. By disseminating high-quality services in small animal phenotyping, the Core is an important
strength for assuring that research is promoted across the full spectrum of translational research. The
productivity numbers and data in the core utilization table speak for themselves. During the last grant cycle, the
APC has been extremely active supporting 210 funded projects from 154 investigators conducting diabetes
research. Moreover, the data provided by the core became the basis of numerous federal grants and led to many
high-quality publications.

Public health relevance
The Animal Physiology Core facilitates the study of animal models for investigators in the Diabetes Research Center at the University of Alabama at Birmingham. These studies of diabetes and cardiometabolic disease are conducted in ways that are relevant to human patients, and include regulation of glucose metabolism, how body weight is regulated and predisposes to diabetes, cardiovascular risk factors, effects of diets, and how genes cause diabetes. The humane use of animals is critical if we are to better understand mechanisms, develop new medications, and make research advances on behalf of our patients.